Determining the role of reward circuits behind different paternal care behaviors and the motivation to care for offspring by comparing two animal models

Summary
Parental neglect is common and highly detrimental to healthy human development. Therefore, a better
understanding of the biology of parental care behavior and the motivation to care for offspring is critical. In
mammals, robust paternal care is observed almost exclusively in monogamous species. To discover the neural
circuitry supporting paternal care in monogamous species, we propose to develop and use state-of-the-art
molecular and neuroscientific tools to study parental behavior in two closely related species of Peromyscus
mice —one monogamous and one promiscuous— with extreme differences in paternal care.
We have established a pup retrieval paradigm for Peromyscus mice that we analyze using multi-angle
videography and machine-learning pose-estimation algorithms. Furthermore, we have set up viral expression
and surgery techniques for fiber implantation such that we can image and manipulate neural circuits in freely
moving Peromyscus mice using fiber photometry.
First, we will quantify pup retrieval behavior —an essential component of parental care in rodents— with sub-
second resolution over long periods of time using statistical behavioral clustering and classification. Then, we
will identify differential neuronal activity and dopamine signatures in the reward system of Peromyscus mice
during pup retrieval. Finally, we will optogenetically manipulate nodes of the dopaminergic reward network and
analyze the effects on species- and sex-specific pup retrieval behavior.
Our experimental and analytical approach will establish Peromyscus as a model system for detailed behavior
and neural circuit analysis, combining the rich behavior displayed by this genus with modern neural circuit
analysis tools. This work will discover circuit principles responsible for the vast range of parental interactions
with infants, from neglect to robust parental care.

Public health relevance
Project Narrative Parental care is critical to child survival and healthy human development, yet we know little about how the brain controls parental care and about variation in parental behavior between individuals and species. We intend to study how motivational neural circuits generate species- and sex-specific variations of parental care behavior using two species of Peromyscus mice with dramatically different levels of paternal care. This work will discover circuit principles responsible for the vast range of parental interactions with infants, from neglect to robust parental care.